TUMOR VIRUS EXPRESSION IN VITRO AND IN VIVO

This program studies oncogenes and papillomaviruses. Oncogene studies have involved ras and EGFR. To identify cellular ras targets, we have made mutants with changed phenotype in a previously determined effector domain of p21-ras protein and mapped the region of p21-ras with which GAP (GTPase activating protein). which is a cellular protein, interacts to this effector domain. The results suggest that GAP may be a target of p21-ras. Experiments with a full-length EGF receptor proto-oncogene placed in a retrovirus vector have shown that increased numbers of EGF receptors can contribute to the transformed phenotype. EGF can serve as a competence and progression factor in cells with high numbers of EGF receptors. In papillomavirus studies, BPV E2 protein has been shown to bind to a specific motif present several times in BPV and other PVs. This motif is an enhancer whose activity depends upon E2. Enhancement requires two or more copies of the motif. Anti-E2 sera have detected three E2 protein products in BPV transformed cells. The smaller forms of E2, which may competitively inhibit enhancement by the full-length E2 product, contain the DNA binding activity but lacks enhancer activity. The E7 ORF of HPV-16 is the principal viral transforming gene for NIH 3T3 cells. These results support the hypothosis that E7 can contribute to the transformed phenotype in human tumors.